Assessing the Effects of HIV Cure Strategies in the Gut-associated Lymphoid Tissue

PROJECT SUMMARY
This is a resubmission of an application for a K23 Mentored Patient-Oriented Research Award by Dr. Francesca
Cossarini, an Assistant Professor of Infectious Diseases at the Icahn School of Medicine at Mount Sinai and a
current KL2 Scholar at the same Institution. This application aims to investigate the effects of proposed HIV cure
strategies in the gut-associated lymphoid tissue. Despite the remarkable progress in the survival and quality of
life of people living with HIV, forty years from its first discovery, HIV infection remains uncurable due to the
persistence of a small pool of cells harboring the virus that can replicate if antiretroviral treatment is stopped.
These cells constitute the HIV viral reservoir and efforts to identify and eliminate these cells have been ongoing
for the past decades. Most of these studies so far have evaluated the effects of cure strategies in the peripheral
circulation. With this proposal, I aim to evaluate the gut-specific effects of proposed cure strategies. The overall
objective of this proposal is highly significant since a large proportion of the HIV viral reservoir is located in the
gut-associated lymphoid tissue, and there is evidence of cross-infection with the peripheral circulation.
Additionally, although memory CD4+ T represent the vast majority (if not the entirety) of the viral reservoir in the
circulation, other cells likely function as reservoirs in intestinal tissue, however, their response to HIV cure
strategies has not been evaluated. Dr. Cossarini is establishing herself as a physician-scientist in the field of HIV
pathogenesis, remission, and cure. She has a specific interest in the role of gut-associated lymphoid tissue in
the establishment and maintenance of the HIV reservoir, an area that has received less attention in the field
compared to systemic circulation but is nonetheless critical for any strategy looking at potential cure strategies.
The results of this study will contribute to addressing a gap in knowledge in the field of HIV cure strategies and
will allow the PI to acquire robust data that will be tested in future research applications. With the completion of
this proposal, the PI will also be able to further her knowledge in the field and master the analytical and laboratory
skills to successfully transition to independence.

Public health relevance
PROJECT NARRATIVE Forty years after its first discovery, HIV infection remains uncurable due to the persistence of a small pool of cells harboring the virus in a latent state (viral reservoir), a large proportion of which is located in the gut- associated lymphoid tissue. Several strategies to eliminate the viral reservoir have been on the HIV cure investigational pipeline, but most of their effects have been evaluated in the peripheral circulation. With this application, I propose to evaluate the effects of cure strategies in the gut-associated lymphoid tissue.